Administrative Core (with Enrichment Program)

Abstract/Summary
Administrative Core. The UCSF Diabetes Research Center (DRC) provides Programs and Cores that foster
research collaborations and interactions to accelerate the pace of T1D research. The Administrative Core is
charged with providing leadership that responds nimbly to the current and future needs of DRC members. The
Administrative Core is responsible for evaluating and setting the goals of the Center and for allocating and
coordinating Center resources to ensure that the DRC evolves in alignment with those goals. The Administrative
Core realizes these tasks by providing a defined governing structure that coordinates leadership, infrastructure,
administrative support, advice and oversight to all DRC activities.
The Center Co-Directors (or when absent, the Associate Director) provide day-to-day leadership and interact
regularly with the Directors of the DRC Research Programs, DRC Cores, DRC members and administrative staff.
The Center Co-Directors and 6 other DRC members from the range of different research programs in the DRC
constitute the Executive Committee. The UCSF DRC interfaces with its membership, the NIDDK, other NIH
Diabetes Centers, and the lay community through the Center Director and the Executive Committee and through
outreach programs including the Enrichment Program, the Pilot & Feasibility grant program, DRC service/training
Cores and the UCSF DRC web site.
The Executive Committee is the major, governing body that sets the long-range goals of the DRC and assesses
how well the Programs and Cores achieve them. The Executive Committee meets quarterly and, when
necessary on an ad hoc basis, to consult with and provide guidance to the Director of the Pilot & Feasibility
Program, the Director of the Enrichment Program and the Core Coordinating Committee, which consists of all
three DRC Core Directors, the Director of the UCSF CoLabs, and DRC Co-Director Dr. Ku, who oversees the
day-to-day coordination of Core activities. The Core Coordinating Committee discusses issues and solutions
related to Core operations and the provision of Core services to the DRC membership. The Executive Committee
also evaluates proposals from the Core Directors and Core Managers for the development of new Core services
and triages DRC support for those service development proposals according to current and future DRC needs.
The Executive Committee also evaluates the external reviews from the Pilot & Feasibility applications, ensures
continuing mentorship and advice to Pilot & Feasibility grant recipients and evaluates DRC membership. The
Executive Committee meets annually with an External Advisory Committee which provides valuable insights into
the scientific and operational directions of the DRC. A biannual meeting of the Executive Committee with an
Internal Advisory Committee, which consists of institutional leaders with interests in DRC-related research,
coordinates DRC progress in relationship with developments and goals throughout UCSF. The Administrative
Core thus coordinates all DRC activities to coordinate the future of T1D research at UCSF.